Synaptic defects caused by mitochondrial complex I dysfunction

PROJECT SUMMARY
Background and Objectives: Neurons and their synapses require high amounts of energy to sustain normal
levels of activity. Mitochondria are the main energy source, producing ATP via oxidative phosphorylation. In turn,
oxidative phosphorylation proceeds through the action of large protein complexes, like Mitochondrial Complex I
(MCI). But much work shows that mitochondrial components in neurons and at synapses also do far more than
generate ATP. Mitochondria buffer calcium, drive Reactive Oxygen Species (ROS) signaling, and influence cell
survival. Using the Drosophila melanogaster neuromuscular junction (NMJ) as a model synapse, we found loss
of MCI components impact distinct synaptic tissues in profoundly different ways. The objective of this proposal
is to use this model to understand exactly how mitochondria impact discrete parts of the synapse.
Specific Aims and Research Design: We found that MCI impairment causes profound cytological abnormali-
ties at both the pre- and postsynaptic NMJ. But important differences emerged upon examination of individual
tissues. NMJ activity is dampened when MCI is impaired in the postsynaptic muscle. NMJ activity can also be
dampened when MCI is impaired in neurons – but curiously, this only happens when it is combined with other
insults. This project has two specific aims. Aim 1 is to understand how loss of MCI in the muscle causes a
diminishment of NMJ function. This phenotype is noteworthy for multiple reasons. First, the NMJ displays phe-
notypes reminiscent of neurodegeneration when MCI is lost in muscle. Second, the NMJ is known to employ
numerous muscle-to-nerve signaling paradigms to sustain normal activity. We can test if any of those retrograde
signals are occluded. Aim 2 is to define how the presynaptic neuron eludes dysfunction when MCI is lost. Com-
bining genetics, pharmacology, electrophysiology, and imaging we will test if known homeostatic signaling com-
ponents and modalities are co-opted to maintain normal activity. The expected outcome of our work is new
understanding of how mitochondrial function and dysfunction impinge upon discrete synaptic compartments.
Health Relatedness: Impairment of mitochondria is associated with neurodegenerative conditions like Parkin-
son’s Disease, neuromuscular conditions like Leigh Syndrome, as well as forms of epilepsy and ataxia. For any
genetic disease or disorder caused by mitochondrial dysfunction, we require better cell-specific models to eluci-
date what is happening on the levels of synapses and circuits. Based on our data, the tractable Drosophila NMJ
is a good way to define how synapses react to normal mitochondrial function or dysfunction. In turn, this kind of
foundational information from the NMJ model could edify downstream investigations into neurological conditions
caused by mitochondrial dysfunction, like forms of Parkinson’s disease, epilepsy, and ataxia.

Public health relevance
PROJECT NARRATIVE Health Relevance Narrative: Loss of mitochondrial function can be debilitating in the nervous system, as evident from its association with numerous neurological diseases and disorders – including forms of Parkinson’s Disease, Leigh Syndrome, or other movement disorders. In order to develop more effective treatments for mitopathies of the nervous system, we need better understanding of the cellular and synaptic consequences of mitochondrial dysfunction. This proposal addresses that problem, using a genetic model of Mitochondrial Complex I dysfunction.